GROWTH HORMONE SECRETION &BODY COMPOSITION MEASUREMENT IN ADULTS

The purpose of this study is to determine the extent to which body fat, regional distribution of fat, and fitness influence growth hormone (GH) secretion in young, middle-aged, and older adults. These relationships will be examined during spontaneous, fasting and exercise conditions. Body composition will be determined using a 4 compartment model and GH section by frequent sampling. We will also investigate whether the decrease in GH secretion with aging is due to a decrease in GH pulse frequency, amplitude, or some combination of these factors. A total of 38 subjects have completed all admissions; will not study 20 middle-aged subjects; abstract submitted to Endo Soc 97, manuscript reporting control data and body composition measurements in preparation.